Examining the role of adenosine-sensing by macrophages in obesity-induced cardiac inflammation

PROJECT SUMMARY
Tissue-resident macrophages fulfill various niche-specific functions to support tissue-level homeostasis.
Obesity, however, impairs critical homeostatic functions of tissue-resident macrophages and triggers chronic
low-grade inflammation by these cells to promote a spectrum of metabolic deficiencies. Neutralization of
proinflammatory cytokines has yielded modest clinical efficacy in individuals with metabolic syndrome, type 2
diabetes, or cardiovascular disease. This has shifted the focus of potential immunotherapies to elucidating
upstream signals driving disease phenotypes rather than targeting byproducts of inappropriate activation states.
Extracellular metabolites can act as signaling molecules to control macrophage function in various disease
contexts. Therefore, the purpose of this application is to uncover novel, tissue-specific metabolite-macrophage
interactions that regulate metabolic inflammation in obesity. Metabolomic analysis of the interstitial fluid (IF) of
different metabolic organs from mice fed a high-fat/high-sucrose diet uncovered adenosine as being the most
upregulated metabolite in the heart IF of obese mice. Adenosine is a purine nucleoside intimately involved in
feedback loops that maintain tissue integrity in response to cellular injury or stress. In line with this, the
preliminary studies described in the proposal demonstrate that adenosine decreases metabolic-stress
associated inflammation in macrophages. These findings led to the hypothesis that adenosine-sensing by
cardiac macrophages represents an adaptive immunometabolic checkpoint that limits aberrant cardiac
inflammation in obesity. This proposal describes two aims to test this hypothesis. Aim 1 will determine how the
extracellular adenosine-macrophage axis regulates cardiac inflammation in obesity. Aim 2 will provide
mechanistic insight into critical signaling pathways underscoring the immunosuppressive function of adenosine
in metabolically activated macrophages. Overall, the experiments in the research proposal will provide a
framework for therapeutic strategies focused on reducing cardiomyopathies in individuals with obesity. In
addition to the research proposal, this application is equipped with a training plan to prepare the applicant for an
academic career as a principal investigator studying how immune and cardiometabolic systems interact in health
and disease. The applicant’s choice of sponsors, institutions, and career development activities place the
applicant in an optimal environment to receive direct training in both immunology and cardiovascular physiology,
as well as strengthen critical skills required to run an independent research program. Overall, the research and
training goals described in this application will foster the development of an upcoming principal investigator set
on contributing to the field of immunometabolism.

Public health relevance
PROJECT NARRATIVE Alterations within the local extracellular metabolite milieu can have a profound impact on tissue-resident macrophage functions. This project seeks to uncover a novel extracellular metabolite-macrophage interaction that modulates deleterious cardiac inflammation in obesity. Overall, findings from this proposal will provide a framework for therapeutic strategies focused on reducing cardiomyopathies in individuals with obesity that are susceptible to adverse cardiovascular events.